SURVIVAL ANALYSIS AND RELATED TOPICS

An international workshop on "Survival Analysis and Related Topics" is proposed. This workshop would to be held at the Ohio State University in Columbus Ohio during the period June 23-28, 1991. The goal of this workshop is to bring together researchers with a common interest in developing methodology in survival analysis, including biometricians, reliability experts, demographers and economists. Both the classical and Bayesian viewpoints will be represented.